Nuclear Organization and Dynamics of Mediator and RNA Polymerase II in Living Stem Cells

PROJECT SUMMARY/ABSTRACT: The Mediator protein complex functions as a coactivator of RNA
Polymerase II (Pol II) transcription in eukaryotic cells. Mediator interfaces the interaction between Pol II and
transcription factors to efficiently regulate gene expression. It is critical for integrating the signal of transcription
factors bound at cis-regulatory chromatin elements (enhancers) that are believed to loop to active gene loci.
Misregulation of gene expression leads to disease, including cancer and developmental disorders. Yet, the
organization of Mediator and Pol II, and the mechanism by which they interact to regulate gene expression is
unknown to date. Our long-term goal is to dissect the biophysical mechanisms and principles underlying the
highly-regulated control of gene expression in eukaryotic cells. The objective of this grant is to characterize the
spatiotemporal organization of Mediator and Pol II in live cells. The central hypothesis is that Mediator and Pol
II form functional clusters with other transcription factors at enhancer DNA elements, then those enhancer
associated clusters can dynamically associate with promoter DNA to activate gene expression. Our rationale is
that direct measurements of Mediator and Pol II interaction will provide important insight into how expression of
genes in eukaryotic cells is regulated. Our specific aims will test the following hypotheses: (Aim 1) to determine
the mechanisms by which condensates of Mediator and Pol II affect gene expression (Aim 2) to determine the
dynamics and functional relevance of the transient population of Pol II and Mediator clusters for gene
expression in living cells (Aim 3) to determine how changes in cluster composition result in different functional
and Dynamic Properties. Upon conclusion, we will understand the mechanisms by which Mediator and Pol II
clusters, both the persistent condensates (~10% of cluster population in stem cells) and transient clusters
(90% of the population in stem cells), act to regulate gene expression in living cells. This contribution is
significant since it will lead to a new paradigm for describing how transcription is regulated in eukaryotic cells
with important implications for development and disease. The proposed research is innovative because we
investigate the spatiotemporal organization and mechanism of interaction between Mediator and Pol II at the
single-cell level and with super-resolution methods. Insight into how clustering affect transcription is impactful
as it provides new avenues for understanding how long-range enhancer-promoter interaction dynamically
control of gene expression, and thus how its misregulation may occur in disease.

Public health relevance
Project Narrative Improved understanding of the role of sub-nuclear organization of Pol II and Mediator in eukaryotic transcription in the cellular context will have broad implications for human health: the regulation of transcription is primordial for cellular homeostasis, and aberrant cellular regulation of transcription has been linked to many maladies including cancer and developmental disabilities.